Core C: Microscopy

Abstract/Summary
Core C: Microscopy.
Purpose: The BIDC (Biological Imaging Development Center) Microscopy Core assembles, tests, and applies
advanced light microscopy and image analysis technologies, providing standard and custom light microscopy
approaches and data analysis to the DRC community, with the lowest possible barrier of entry. From 2021-2024,
laboratories affiliated with the proposed type 1 diabetes centered DRC user group averaged nearly 4000 hours
of Microscopy Core use per year. The Microscopy Core maintains several high-end microscope systems
including two Leica SP8 and one Leica Stellaris laser-scanning confocal microscopes, a Nikon CSU-W1/SoRa
super-resolution spinning disk confocal microscope, a home-built and a commercial Nikon A1R multiphoton
microscope as well as several lower end microscope systems and custom solutions such as a homebuilt lattice
light sheet microscope, and image analysis workstations. High value services offered by the Microscopy Core
include but are not limited to:
· Access to and customized training for advanced confocal and multiphoton fluorescence microscopy.
· Access to innovative new technology currently developed or pursued by the Microscopy Core.
· Access to tissue slicing and histology services and whole mouse body imaging.
· Access to high end image analysis and customized expertise in post-acquisition data analysis.
DRC users will receive comprehensive individual training on Microscopy Core instruments and image processing
stations that reflects their experience, aptitude, and needs at a reduced cost. In addition, the DRC Microscopy
Core offers consultation to DRC investigators free of charge to assist specifically with diabetes-related
microscopy projects, such as for example the development of live pancreatic islet imaging under perfusion
conditions.
Benefits to the DRC Community: The Microscopy Core provides DRC investigators access to advanced imaging
technology in a practical and economic fashion. For this funding cycle, 25 different DRC laboratories with a
variety of diabetes-related projects and grant support totaling more than $12.8M in annual direct costs will benefit
from the Microscopy Core.
Technology Development: The Microscopy Core continues to evolve to meet demand and aggressively pursue
implementation of state-of-the-art innovative technologies. Ongoing development projects include commercial
and homebuilt light sheet systems for large volume cleared tissue specimens such as whole mouse pancreas or
human biopsies, and live organoid microscopy, advanced multiphoton microscopy, and spatial proteomics and
multiplex immunofluorescence platforms.